A Phase II Evaluation of the Safety and Protective Efficacy of the Live Attenuated Tetravalent Dengue Vaccine TetraVax-DV with Challenge by the Recombinant DENV-2 Virus in a Dengue Endemic Population

PROJECT SUMMARY
Dengue viruses cause more human morbidity than any other arbovirus, underscoring the public health
urgency of making safe and effective dengue vaccines available in endemic settings, in alignment with NIAID
priorities. This critical need will be addressed by testing the safety and protective efficacy of NIAID's lead
tetravalent, live attenuated dengue vaccine candidate, TV005, in adults in dengue-endemic Bangladesh
through a vaccine-challenge trial based on the Dengue Controlled Human Infection Model (D-CHIM). Our
central hypothesis is that vaccination with TV005 will protect against infection with a live, recombinant dengue
2 challenge virus (DENV-2), with DENV-2 viremia following challenge as the primary efficacy endpoint. In
addition to extensive Phase I and II trials leading to the development of TV005, our team has used a similar
vaccine-challenge design to evaluate the safety and efficacy of TV005 in dengue-naïve U.S. adults, which was
well-tolerated and >99% efficacious in preventing viremia. The next critical step for NIAID's promising vaccine
is to test its safety and efficacy in a dengue-endemic setting. In this study, 224 healthy adult volunteers, both
dengue-exposed and -naïve, will be enrolled and randomized 1:1 (vaccine: placebo) to receive TV005 followed
by inpatient challenge with DENV-2 at 6 or 24 months post-vaccination. To test our central hypothesis, we will
pursue the following Specific Aims: Aim 1A) Determine, in a dengue endemic population, the protective
efficacy of TV005 vaccine against dengue infection induced by a live, recombinant DENV-2 challenge virus
(rDEN2∆30-7169) administered 6 or 24 months after vaccination; Aim 1B) Evaluate the safety of TV005 and
the DEN-2 challenge virus in a dengue endemic population; and Aim 2) Use predictive modeling to identify
baseline and post-vaccination immune phenotype(s) that predict TV005 efficacy and safety to better
understand response to vaccination and protective immunity, and to inform future study design for dengue
vaccine development in endemic settings. In contrast to large-scale field trails, the D-CHIM will provide early
vaccine efficacy and safety signals while enrolling a minimal number of volunteers, and contribute to our
understanding of the immune response to both vaccination and challenge in an endemic setting through
statistical modeling of vaccine impact.

Public health relevance
PROJECT NARRATIVE Dengue viruses has been identified in 128 countries, exposing nearly 4 billion people, over half the world's population, to risk of dengue disease. There is an urgent need to make safe and effective dengue vaccines available, particularly in areas where dengue is endemic. This study will use a specialized vaccine-challenge trial design to test the safety and efficacy of the NIH's lead dengue vaccine candidate, TV005, in dengue- endemic Bangladesh as the critical next step in product development of this promising vaccine.